Function- and interaction-based discovery of negative allosteric modulators of the A2A Receptor

Project Summary
Immune checkpoints are critical for maintaining immune homeostasis. They prevent overactivation of
the immune response. However, aberrant activation of immune checkpoints pathways in certain
cancers reduces anti-tumor immunity allowing tumors to proliferate. Therapies targeting immune
checkpoints CTLA4, PD-1 and PDL-1 have been successful in treating a wide variety of refractory
cancers. However, their efficacy is limited to a small percentage of patients highlighting the need for
targeting additional immune checkpoint pathways. In this regard, the blockade of adenosine-adenosine
A2A receptor (A2AR) immune checkpoint activation with high-affinity antagonists has shown promise in
preclinical studies. As antagonists block adenosine-A2AR immune checkpoint globally, adverse events
are anticipated. In contrast, negative allosteric modulators (NAM) conceivably block the activation of
adenosine-A2AR immune checkpoint only at tumor sites where adenosine levels are elevated. We
envision that blocking the adenosine-A2AR immune checkpoint activation with NAMs is disease-site
specific and thus a more directed approach to enhance anti-tumor immunity. We have demonstrated
previously that adenosine-A2AR immune checkpoint is amenable to positive allosteric modulation
through synthetic small molecules. However, negative allosteric modulation of the adenosine-A2AR
immune checkpoint has not been reported. To test our notion, we have designed and synthesized a
library of over 300 compounds potentially containing adensoine-A2AR NAMs. In this proposal, we will
identify A2AR NAMs utilizing in vitro screening paradigms established in our laboratory. Aim 1: Identify
NAMs of the adenosine-A2AR immune checkpoint. (a) The compound library will be screened in a cell-
based cAMP assay utilizing CHO cells stably expressing the A2AR. NAMs will be identified on the basis
of adenosine-mediated inhibition of cAMP production. (b) NAMs will be confirmed in a radiolabeled
agonist binding assay utilizing CHO-A2AR membranes. A reduction in the binding affinity of the A2AR
selective agonist CGS 21680 is indicative of NAMs. Aim 2: Identify NAMs with best immune-enhancing
activity and A2AR selectivity. (a) NAMs will be screened for their ability to reverse the adenosine-A2AR-
mediated inhibition of IFN-g production by a-CD3/CD28-stimulated CD8+ T cells. (b) NAMs with the
best immune enhancing activity will be evaluated for A1R, A2BR and A3R activity in cell-based cAMP
assays utilizing cell lines stably expressing the receptors. If successful, this will be the first identification
of NAMs of the adenosine-A2AR immune checkpoint and demonstration of a novel approach targeting
the same.

Public health relevance
Project Narrative Cancers escape immune cell-mediated killing by activating natural suppressive mechanisms that prevent overactivation of the immune response. The focus of the current proposal is to identify synthetic small molecules that block the activation of a key natural immune suppressive mechanism and enhance the anti-tumor response.